Transcriptional Control of Cellular Survival and Proliferation in KSHV-transformed B Cells

SUMMARY
Kaposi’s sarcoma-associated herpesvirus (KSHV) is a major cause of cancer in the context of HIV/AIDS. We
recently showed that KSHV-transformed primary effusion lymphoma (PEL) cell lines exhibit a strong requirement
for the cellular lymphoid transcription factor IRF4. This finding places PEL into an emerging group of blood
cancers where IRF4 is a key oncogenic driver. A detailed understanding of the oncogenic roles of IRF4 has not
been achieved in any of these cancers, but evidence suggests that IRF4 functions as a master transcription
factor that induces extensive epigenetic and transcriptional reprogramming. In PEL, IRF4 is required for
overexpression of the MYC oncogene, but how KSHV controls IRF4, the molecular mechanism by which IRF4
regulates MYC, and whether IRF4 acts solely through MYC or has additional oncogenic roles is unknown. The
long-term objective of this proposal is to determine the downstream effects that underlie the oncogenic roles of
IRF4 in PEL and to use our results to develop novel therapeutic strategies. The central hypothesis of this
proposal is that KSHV-induced, IRF4-dependent oncogenic transcriptional reprogramming is required for tumor
cell survival and proliferation in PEL. This hypothesis is premised on our extensive preliminary work, which has
identified both KSHV-encoded and cellular transcription factors that control IRF4 expression and function in PEL.
Based on ChIP-Seq and mRNA-Seq experiments, we specifically hypothesize that IRF4, together with its viral
and cellular co-factors, associates with promoters and distal cis-regulatory elements to drive an IRF4-dependent
oncogenic transcription program, which involves both the silencing of “toxic” tumor suppressors and the
overexpression of several essential survival genes, including MYC, but also others. To test our hypothesis, we
propose two Specific Aims, i.e. we will: (1) determine which toxic genes must be silenced by IRF4 to promote
PEL cell viability and proliferation, and (2) determine which IRF4-stimulated genes are essential IRF4 effectors
in PEL cells. Several of the already identified candidates for IRF4 effectors are high-confidence drug targets. We
will therefore exploit our results in both aims to identify and test novel therapeutic strategies, in vitro and in vivo.
This work uses a cutting-edge approach that integrates hypothesis-driven experiments with unbiased functional
genomics approaches. The proposed study is innovative, because the oncogenic outcome of transcriptional
reprogramming in the context of KSHV-associated malignancies has not been studied. The proposed work is
significant, because it will uncover oncogenic roles of IRF4 in KSHV-mediated B cell proliferation and survival.
In addition, results will inform our understanding of IRF4 in B cell biology and its oncogenic role in several
hematopoietic malignancies. Results will be impactful, because our studies of IRF4 dependency are expected
to result in improved strategies for therapeutic intervention in this incurable cancer.

Public health relevance
PROJECT NARRATIVE Kaposi’s sarcoma-associated herpesvirus (KSHV) is a major cause of AIDS-associated malignancies and thus represents a significant public health burden. The proposed work will identify specific genes and DNA elements that mediate the cancerous reprogramming that occurs in KSHV-associated B cell lymphomas. Results will be impactful, because they will be used to develop therapeutic strategies for this presently incurable cancer.